Using Natural Language Processing and Crowdsourcing to Monitor and Evaluate Public Information and Communication Disparities about Colon Cancer Screening

PROJECT SUMMARY
Colorectal cancer (CRC) incidence and death rates are higher among Black Americans than non-Hispanic
White Americans. While some CRC-related disparities have decreased (e.g., incidence and stage of
presentation), disparities persist in the context of CRC screening (CRCS) and knowledge of certain risk factors
(e.g., alcohol use). Studies suggest that supportive and information-rich social networks, both online and
offline, could improve CRC outcomes among Black Americans. A growing body of evidence indicates the
importance of online sources of health information seeking and scanning about CRC, but little is known about
the impact of the messages that individuals are encountering on these platforms. Research on the content and
volume of messages White and Black Americans encounter from online health information sources is still
unclear—particularly regarding any disparities that exist about what specific information is sought, scanned, or
shared by Black Americans. There is a critical need to understand which messages resonate among
populations at-risk for specific diseases (e.g., CRC) and who may have concerns about engaging in early
prevention (e.g., reduce alcohol use) and detection (e.g., CRCS) behaviors. The proposed project utilizes and
applies novel cancer communication surveillance approaches (e.g., natural language processing and
crowdsourcing) to examine public health communication about CRC prevention and control. Extension Aim 1
will use computational approaches to capture and analyze digital and social media information about CRC.
This approach offers an efficient, effective, and responsive method to monitor (mis)information and emerging
messages about CRCS. Aim 2 will use a crowdsourcing approach (wiki surveys) to assess population
perceptions of public information and artificial intelligence (AI)-generated messages about CRC. The project
will offer evidence to help determine the validity and scalability of these novel methods, which is essential to
innovate formative research and evaluation approaches in the future.

Public health relevance
PROJECT NARRATIVE Efforts to improve public health communication about colorectal cancer (CRC) requires understanding what information is commonly seen by target audiences and consideration of existing information and behavior disparities for populations at higher risk for CRC (e.g., Black Americans). The current project uses novel computational approaches to monitor the public communication environment about CRC and crowdsourcing to engage in formative evaluation of possible message content. The project tests novel approaches to monitor and evaluate public health information to inform health communication research and practice.